COMPASS Ancillary NeuroDevelopmental Outcomes(CAN-DO)

PROJECT SUMMARY/ABSTRACT
Neurodevelopmental (ND) impairment is the most common morbidity for individuals born with critical congenital
heart disease (CHD) such as ductal-dependent pulmonary blood flow (DDPBF). This results in high individual,
familial, and societal burden. Clinical and sociodemographic factors have been shown to impact ND outcome,
and the interventional approach for cardiac repair may also play an important role. For neonates with DDPBF,
recent preliminary studies have shown that using transcatheter ductal arterial stenting (DAS) in lieu of surgical
systemic-to-pulmonary artery shunting (SPS) may result in improved survival and shorter length of stay but these
studies have not examined differences in ND outcomes. These studies led to the COmparison of Methods of
Pulmonary blood flow Augmentation in neonates: Shunt versus Stent (COMPASS) Trial, a multicenter
randomized controlled trial currently being conducted through the Pediatric Heart Network, that will compare
cardiac morbidities and mortality within the first 12 months of life in 300 neonates with DDPBF randomized to
SPS or DAS intervention but does not include ND outcomes. The enclosed proposal is an ancillary prospective
longitudinal ND study of COMPASS-eligible patients that will compare ND outcomes at 36-months of age
between the SPS and DAS groups using a multivariable model to account for pre-procedural medical and
sociodemographic risk factors for ND impairment. Candidate biomarkers of neural injury will be measured peri-
operatively to evaluate for differences by intervention approach and assess their predictive utility for ND
outcomes, while targeted biomarkers of neural development will be measured peri-operatively and at 36-months
to determine their relationship to ND outcome. Broader multi-omics analyses will assess for interactions between
the genome, proteome, and exposome (including medical exposures and social determinants of health) for
predicting 36-month ND outcomes. We will test the following hypotheses: 1) After controlling for known pre-
procedural risk factors for ND impairment (medical, sociodemographic, and genetic factors), children who
underwent DAS will have better ND outcomes at 36-months of age compared to those who underwent SPS, 2)
Perioperative candidate biomarkers of neural injury and longitudinal biomarkers of neural development will
improve prediction of ND outcomes in both neonatal intervention groups, and 3). Proteomic, genomic, and
exposomic risk factors will interact to further predict 36-month ND outcomes. Results from this proposal will
contribute important ND outcome data for the COMPASS Trial and, more broadly, improve our understanding of
the ND burden in this patient population through developing the most comprehensive predictive model to date
for ND outcomes in children with critical CHD. Our ultimate goal is to identify interventional targets to improve
ND outcomes in DDPBF and to inform precision medicine strategies for selecting the neonatal intervention
approach based on patient-specific factors to optimize ND outcomes. Finally, this proposal will establish a robust
framework for leveraging existing clinical registries to incorporate ND outcomes in future clinical trials in CHD.

Public health relevance
PROJECT NARRATIVE The COmparison of Methods of Pulmonary blood flow Augmentation in neonates: Shunt versus Stent (COMPASS) Trial is a randomized controlled trial being conducted through the Pediatric Heart Network, comparing medical morbidity and mortality outcomes of two neonatal intervention approaches for ductal dependent pulmonary blood flow (DDPBF). We propose a prospective observational study of COMPASS-eligible participants, leveraging the infrastructures of multiple clinical cardiac registries, to understand the effect of the intervention strategy on neurodevelopmental outcomes at 36-months for children with DDPBF and determine the predictive utility of candidate biomarkers of neural injury and neural development. Findings will contribute crucial additional outcome data to the COMPASS Trial and will generate targets for intervention and precision medicine approaches to improve neurodevelopmental outcomes in children born with DDPBF.